Brain extracellular matrix changes during normal aging and in Alzheimer disease

Project Summary/Abstract
The long-term objective of this application is to identify novel biomarkers for early diagnosis and/or
prognosis prediction of Alzheimer’s disease (AD), a neurodegenerative disorder that affects 5.5 million
people in the US. This is consistent with the mission of NIA. This proposal aims to determine brain
extracellular matrix (ECM) composition changes during normal aging and in AD in both rodents and
humans using an innovative decellularization-based proteomic approach. In Aim 1, Mouse ECM
composition in different brain regions and at various ages will be determined using an innovative
decellularization-based proteomic approach optimized in our laboratory. In Aim 2, brain ECM
composition changes in both 5xFAD and PS19 mouse models of AD will be investigated similarly.
Different brain regions and various ages (representing distinct stages of AD) will be analyzed to
determine any region-specific and age-dependent changes. In Aim 3, ECM composition alterations in
human AD brains will be explored using postmortem prefrontal cortex samples from AD patients and
age/gender-matched controls. In addition, the contributions of CAA (a vascular pathology frequently
found in AD brains) and ApoE4 (a major genetic risk factor for AD) in ECM composition will be
determined by including samples with and without CAA and ApoE4 in each condition. Successful
completion of this study will establish ECM composition in mouse brains in a region-specific manner,
elucidate ECM changes during normal aging, characterize the temporary and spatial changes of the
ECM in two mouse models of AD, and determine ECM alterations in AD patients. These findings will
provide a comprehensive picture on how each ECM protein changes during normal aging and in AD in
any brain region at any time, which will pave the way for future research and substantially move the
field forward. This proposal may lead to the identification of novel biomarkers in early AD diagnosis
and/or prognosis prediction.

Public health relevance
Project Narrative Alzheimer’s disease (AD), the most common form of dementia, is a neurodegenerative disorder that affects 5.5 million people in the US. This proposal characterizes brain extracellular matrix (ECM) composition changes during normal aging and in AD in both rodents and humans using an innovative decellularization-based proteomic approach. Successful completion of this study: (1) will elucidate ECM composition changes during normal aging and in AD pathogenesis in both rodents and humans and (2) may lead to the identification of novel biomarkers in early AD diagnosis and/or prognosis prediction, which will pave the way for future research and substantially move the field forward.